Effect Of Diet and Other Early Exposures on Child Health and Development

Diet and other early exposures may affect child development and the risk of several chronic diseases, but additional research is needed. [unreadable] [unreadable] The current research described in this catch-all project comprises two project, described below[unreadable] [unreadable] We conducted a study of risk factors for nonalcoholic fatty liver disease among adolescents. This study took advantange of newly available data from the National Health and Nutrition Examination Survey, 1999-2004. The prevalence of this potentially serious condition was found to be suprizingly high--8%.[unreadable] [unreadable] We also conducted a study of determinants of age at menarche among young women in the Collaborative Perinatal Project. The main finding was that, in contrast with a previous study, that exposure to cigarette smoke in utero was unrelated to subsequent age at menarche.[unreadable] [unreadable] Last years progress:[unreadable] Two papers were published (see list below).